Deep-learning assisted photoacoustic histology for real-time intraoperative pathological diagnosis

Project Summary
Despite the advances in cancer treatment, surgery remains the cornerstone, and more than 80% of cancer
patients have a surgical procedure at some point in their cancer evolution. In oncology surgery, intraoperative
pathology provides surgical guidance and identification of tumor margins, allowing confirmation of complete
tumor resection before oncology surgeons close the surgical wound and helping patients avoid a second tumor
resection surgery. Most localized tumors with negative margin resection show improved patient outcomes and a
lower chance of tumor recurrence. However, the intraoperative frozen section technique suffers from a series of
limitations: tissue loss, compromised quality due to freezing artifacts, suboptimal cutting of fatty specimens, and
inability to diagnose bony lesions.
In our preliminary results, we have developed the 3D contour scanning ultraviolet photoacoustic microscopy (UV-
PAM) to acquire histology-like images of thick bone specimens, which addresses the long-standing challenge of
intraoperative bone histology. The rapid photoacoustic histology images of bone specimens well match the
conventional histology images stained by hematoxylin and eosin (H&E), allowing pathologists to identify the
cancerous features following existing pattern recognition parameters readily. Although these results showed the
feasibility of intraoperative photoacoustic histology of bone specimens, the system has a relatively slow imaging
speed fundamentally limited by the low laser repetition rate of UV lasers and applies only to only bone specimens.
This research proposal aims to develop a high-throughput photoacoustic histology platform for pathologists and
surgeons to diagnose intraoperatively and remotely with an imaging speed at least 100 times faster than any
published reflection-mode UV-PAM systems.
Specific Aim 1: Develop a structured illumination UV-PAM for ultrafast histology imaging of slide-free
specimens. Aim 1.1. We will develop an ultrafast reflection mode UV-PAM using multifocal illumination with a
single element transducer. Aim 1.2. We will design and fabricate DOEs for structured illumination UV-PAM with
an extended depth of focus for slide-free specimens with irregular surfaces to allow high-throughput imaging of
slide-free specimens in clinical settings.
Specific Aim 2: Implement neural networks for virtual staining of photoacoustic histology and real-time
intraoperative diagnosis. Aim 2.1. We will implement neural networks and unsupervised deep learning
techniques to virtually stain photoacoustic images in various tissue types. The utilization of virtual stained PAM
images for intraoperative diagnostic will be evaluated by pathologists in clinical practices. Aim 2.2. We will
develop and train a deep learning neural network to classify tumor types and stages in different tissues using
photoacoustic histology to build a computer-aided platform for real-time intraoperative diagnosis.

Public health relevance
Project Narrative The rapid histopathological examination can allow for an accurate intraoperative diagnosis and confirm negative tumor margins in the resected tissue (i.e., suggesting all of the cancer has been removed), providing surgical guidance and avoiding second surgeries. Currently, the intraoperative diagnosis in clinical practices relies mostly on the frozen section technique, which usually suffers from compromised diagnostic interpretation due to processing artifacts and only applies to limited tissue types. To address these challenges, I propose developing the deep learning-assisted photoacoustic histology platform to generate readily interpretable computer-aided images for pathologists and surgeons to diagnose intraoperatively and remotely.